INTERINDIVIDUAL VARIABILITY IN ESTROGEN METABOLISM IN POSTMENOPAUSAL WOMEN

To determine the effect of an inhibitor (erythromycin) and an inducer (rifampin) of P4503A4 on the pharmacokinetics of estradiol. This pilot study is complete.